SAXS Core

The mission of the SAXS Core facility is to provide support to research projects from CCR principal investigators (PIs), NIH intramural PIs, and extramural academic research groups/laboratories. The support includes providing routine access to the APS PUP SAXS/WAXS beamline and in-house SAXS instrument, and expertise in experimental design, data collection, processing, analysis, and interpretation. Our main focus is to determine the structure of biomacromolecules and their complexes in solution. The research subjects includes but not limited to structural studies of nucleic acids, proteins, protein assemblies, virus particles, lipid membranes, protein/DNA, and protein/RNA complexes. The COVID-19 pandemic has had a negative impact on the operation of the SAXS facility, because of laboratory shutdowns nationwide that prevents in-lab sample preparation and SAXS experiment for most of 2021. In-person SAXS experiments were only allowed to start by the SAXS beamline in May 2022.